Spillover Effects of Policies Targeting Opioid Abuse on Intimate Partner Violence

OTHER PROJECT INFORMATION – Project Summary/Abstract
Spillover Effects of Policies Targeting Opioid Abuse on Intimate Partner Violence
Intimate partner violence (IPV) is a significant public health problem adversely impacting the physical and mental
health of victims and their children. It remains the most common form of violence experienced by women, with
>30% of women in the U.S. experiencing physical or sexual IPV over their lifetime. An important risk factor
associated with IPV perpetration is substance abuse, which can trigger aggressive behavior and worsen impulse
control problems. As use and misuse of both prescription (Rx) and non-Rx opioids have risen over the past two
decades, this has engendered a public health crisis with far-reaching consequences for individuals, families and
communities. One notable concern voiced by public health experts relates to the intersection of these two public
health crises, and the role played by opioid misuse in facilitating IPV. Among men using opioids, prevalence of
IPV perpetration ranged from 15% (past-year severe/physical IPV) to 58% (lifetime prevalence). Opioid use is
also a risk factor for being a victim of IPV, with 32-75% of women opioid users reporting past year victimization.
Beyond correlational evidence on the co-occurrence of opioid use and IPV, the consequences of the opioid crisis
for IPV have not been systematically explored. There is no causal evidence to date on the intersection of these
two public health crises, and no studies on how interventions targeting opioid misuse are impacting IPV
perpetration and victimization. Our project is significant in providing the first analyses of downstream effects –
positive or negative – of two supply-side interventions targeting the opioid epidemic on the risk of IPV perpetration
and victimization: (i) prescription drug monitoring programs, designed to collect and monitor Rx opioid data for
preventing its misuse and diversion into non-medical uses, and (ii) the reformulation of OxyContin – one of the
most popular Rx opioids for recreational use and abuse – into an abuse-deterrent form in 2010. We will leverage
5 survey and administrative data sources, spanning up to 3 decades, with complementary strengths including
the 1) National Crime Victimization Survey; 2) National Intimate Partner Violence and Sexual Violence Survey;
3) National Incident Based Reporting System; 4) FBI Supplemental Homicide Reports; and 5) National
Epidemiologic Surveys on Alcohol and Related Conditions. These data sets are nationally-representative, have
large sample sizes, and capture IPV across the spectrum of severity, including homicides committed by an
intimate partner, and reporting status (self-reported, reported to law enforcement). Exploring heterogeneity in
these responses by perpetrator/victim characteristics and by access to substance use treatment services will
also allow us to identify vulnerable populations and propose public health policies to address potentially
unintended consequences of policies targeting the opioid crisis. Our project is innovative by using cutting-edge
quasi-experimental methods, including newer “difference-in-differences” methods designed to reduce bias in
estimated treatment effects due to dynamic heterogeneity, to explore dynamic responses in how opioid policies
have impacted the risk of IPV perpetration/victimization.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The proposed research is relevant to public health because it addresses the intersection of two public health crises in the U.S., notably by assessing the extent to which the opioid crisis has contributed to elevated levels of intimate partner violence (IPV). Given the severe adverse consequences of IPV for the physical and mental health of victims and children, understanding whether supply-side policies implemented in response to the opioid crisis have had spillover effects on the risk of IPV perpetration and victimization is critical for evaluating the full societal costs and benefits of these policies, and for identifying sub-populations at heightened risk of IPV exposure. This project will evaluate for the first time the effects of policy-induced changes in opioid use on the risk of IPV perpetration/victimization, and in the process inform a key public health concern relevant to the NIH's mission at the intersection of the opioid epidemic and its impact on violence towards women.